Mobile-based Obstetric Monitoring for Pregnancies Complicated by Hypertension and/or Diabetes (MOM-HD): a Type II Hybrid Implementation-Effectiveness Trial

PROJECT SUMMARY
Hypertensive disorders during pregnancy (HDP) and gestational diabetes (GDM) represent the foremost
complications in pregnancy, significantly contributing to global maternal and fetal morbidity and mortality. Effectively
managing HDP and GDM hinges on regular monitoring of blood pressure (BP) and blood glucose (BG) to ensure
adequate control and timely interventions for maternal and fetal well-being. However, in low-income settings like
Nepal, women encounter difficulties in making frequent healthcare visits due to logistical challenges, thereby
exposing them to risks of uncontrolled BP and BG levels. Telemonitoring offers a promising and cost-effective
alternative by enabling pregnant individuals to monitor BP and BG at home and share real-time results with
healthcare providers, which in turn facilitates informed clinical decision-making and timely interventions. While
remote monitoring has been proven effective in improving BP, BG, and perinatal outcomes among women with
HDP and GDM in high-income countries, its implementation faces challenges in low-resource settings like Nepal. In
our pilot study [R21TW011377-S1], we developed the MOM-HD (Mobile-based Obstetric Monitoring for
Hypertension and/or Diabetes) to address pre-identified barriers by providing financial and technical assistance for
patient self-monitoring of vital signs and delivering comprehensive training and technical support to healthcare
providers, including developing standardized clinical algorithms and quality assurance protocols to facilitate
seamless workflow. Based on promising findings from our pilot work, here we propose to conduct a Hybrid Type II
Effectiveness-Implementation Randomized Controlled Trial (RCT) to assess the effectiveness and evaluate the
implementation of our MOM-HD program in real-world clinical settings in Nepal. To address the study aims, we will
recruit 864 women who are newly diagnosed with HDP and GDM from three metropolitan hospitals and randomly
assign them to either (i) MOM-HD + standard care or (ii) standard care alone, from enrolment in pregnancy to 6
weeks postpartum. Primary and secondary clinical outcomes will be assessed at delivery, and at 6 weeks
postpartum. We hypothesize that compared to standard care, the use of MOM-HD in addition to standard care will
result in lower systolic BP levels, lower incidence rate for the composite adverse perinatal outcome of either
perinatal loss, neonatal intensive care unit admission, primary cesarean delivery or labor induction, and lower
proportion of days with elevated systolic BP or BG readings between recruitment and 6 weeks postpartum. A
convergent mixed-methods approach will be used to assess implementation and maintenance outcomes using the
RE-AIM framework, and economic sustainability will be assessed by collecting primary cost data. If successful, the
study would yield effective implementation strategies to implement a mobile-based telemonitoring program and
enhance clinical management and outcomes among pregnant women with HDP and GDM in other low-resource
countries. Findings from this study will also develop the knowledge, tools and processes needed to broadly
disseminate and scale evidence-based telemonitoring interventions for HDP and GDM in diverse settings.

Public health relevance
PROJECT NARRATIVE Sustainable, scalable and cost-effective solutions are needed to address the growing public health burden and sequelae of hypertensive disorders during pregnancy (HDP) and gestational diabetes (GDM), globally and in low resource countries like Nepal. Leveraging our successful pilot work developing and pilot-testing the MOM-HD telemonitoring program [R21TW011377-S1], this project will test i) its effectiveness in improving clinical outcomes among women with HDP and GDM, in a multi-center, pragmatic randomized controlled trial in Nepal, ii) evaluate implementation outcomes using the RE-AIM framework at the patient, provider, and health system levels, and iii) examine the economic sustainability of MOM-HD to inform potential scale up. The proposed study introduces several innovations that could be applied to guide the future design, testing, implementation, and optimization of telemonitoring programs for HDP and GDM across diverse contexts and settings.